Tissue Culture and Histology Core

SUMMARY – TISSUE CULTURE AND HISTOLOGY MODULE
The Tissue Culture and Histology Module supports and enhances the vision research in Pittsburgh by providing
facilities, services, training, advice and expertise in tissue culture and histology applications. Tissue culture
services include maintenance of routine cultures, as well as applications requiring specialized techniques or
experience. Histology support is focused on the rapid, flexible, and specialized handling of samples for light
microscopy. In addition, the Tissue Culture and Histology Module trains investigators’ staff in the use of module
facilities and techniques, assists with troubleshooting, and consults on experimental design and protocol
development.